EX VIVO GENE THERAPY OF FAMILIAL HYPERCHOLESTEROLEMIA

The purpose of this study is to develop an approach for treating homozygous familial hypercholesterolemia (FH) based on the transplantation of autologous hepatocytes that have been transduced with a normal LDL receptor gene.